Training in Bioinformatics and Integrative Genomics

Project Summary
We propose to continue the Bioinformatics and Integrative Genomics (BIG) pre-doctoral training
program at Harvard Medical School. Since its inception in 2000, this program has provided
rigorous multidisciplinary education in genome sciences for those students with proven
excellence in quantitative areas and deep interest in biological and medical applications. Our
program aims to train independent investigators who are capable of integrating genome-scale
technologies into experimental studies to address fundamental questions in biology and
developing computational methods and mathematical models to interpret large-scale genomic
datasets. The BIG training program draws on three significant strengths of the local academic
environment: the breadth of talented investigators at Harvard Medical School and its affiliated
hospitals and research institutes; the rich variety of quantitatively-oriented courses in
bioinformatics and genomics offered at Harvard and MIT; and national leadership of BIG faculty
in genome-scale disease research, including harnessing of genomic approaches for clinical
applications. The BIG pre-doctoral curriculum includes the following: 1) courses in fundamentals
of genetics and molecular biology, taken alongside graduate students in the biological sciences;
2) statistics and machine learning, with applications to basic biology, population studies, and
clinical medicine; 3) a survey of the larger scope of biomedical sciences, including medical
informatics and translational medicine. This training program will continue to produce leaders in
both academia and industry who are using genomic sciences to advance biomedical research.

Public health relevance
Project Narrative: The Bioinformatics and Integrative Genomics doctoral program at Harvard Medical School provides students trained in the quantitative sciences a deep understanding of molecular biology and genetics, a rigorous experience in modern computational approaches for analyzing large datasets, and a rich environment with faculty mentors who are experts in bioinformatics and genomics. This program will continue to produce leaders who are using genomic sciences to advance biomedical research and clinical practice.